Role of GATA4 and GATA6 in Controlling Heart Development

2 '<-,$[unreadable]:;'-'.. >-'>* - i X. * *.- * ',Role,of'GATA4aml>;GATrA6'mMeontrolling Heart,Development ^ , * t i-'>* \ '[unreadable][unreadable] r [unreadable]i [unreadable] 'rt *. -,, ^[unreadable] [unreadable]*'" ' Sub-